Leptin as a Therapy for Alzheimer's Disease

Leptin has been considered as a novel treatment for Alzheimer’s disease (AD), but we lack adequate evidence of a biological signal indicative of a therapeutic effect in patients with AD. Some concerns are related to side effects, along with uncertainty about dosing. We will therefore perform a pilot study in patients with AD that is sufficient in scope to assess the impact of Leptin on biomarkers selected for their relevance to the mechanism of action of Leptin and the pathobiology of AD. In addition, the study will help clarify tolerability, safety, and feasibility issues relevant for consideration of a larger subsequent trial. The trial may be used as a stepping-stone to a larger and longer multicenter trial in patients with AD or mild cognitive impairment. 45 patients with mild-moderate probable AD and plasma leptin levels of (</=14 ng/ml) will be randomized to treatment with Leptin at two doses (1 and 5 mg daily) or placebo in a double-blind manner for 12 weeks. The enrollment will target recruitment of 50 patients to achieve a sample of 45 study completers. Spinal taps will be performed at baseline and repeated after 12 weeks of therapy. A final visit will occur 4 weeks after cessation of therapy to assess for possible untoward effects of the Leptin therapy or lumbar puncture.

Public health relevance
Leptin is an endogenous peptide. native to the endocrine system and was first discovered and patented by Dr. Jeffrey Friedman of Rockefeller University in 1994. J.eptin supplementation was able to reverse the obesity in the mutant oblob mouse (that docs not make Lcptin) and this raised hopes for an obesity therapy. While the peptide was well tolerated by humans and exhibited an excellent safety profile in clinical trials, it failed to demonstrate eJlicacy for the targeted condition (obesity) as a monotherapy. Seminal preclinical research, published in December 2004, showed that I .eptin augmentation treatment substantially reduced the brain levels of amyloid beta ("AW') in mouse models. j,forc recently, it was shown that Lcptin can also decrease phosphorylation of tau. lmpo11antly, circulating Leptin levels decline in most Alzheimer's disease (AD) patients prior to cognitive dckrioration and continue to gradually decline as the disease progresses. Therefore, Neurotez believes that therapy with a recombinant human Leptin product should he beneficial to AD patients, as a modulator of AP and phospho-tau and as an insulin sensitizer. 1bc latter may be quite significant, as the majority of AD patients arc characterized by hyperinsulinemia or some fom1 of insulin resistance, including type 11 diabetes.